Investigating a dual-pathway framework for praxis

PROJECT SUMMARY
Performing skilled actions relies on two fundamental abilities: imitating movements to quickly learn new
behaviors, and using tools to more efficiently manipulate our environments. Imitation and tool use are critical
for many activities of daily living; loss of these abilities in the clinical disorder of limb apraxia, frequently
observed in many neurological disorders including in ~50% of individuals with left-hemisphere stroke, is the
strongest predictor of increased caregiver dependence and poor post-stroke recovery. Despite the recognized
importance of these abilities, the processing mechanisms underlying imitation and tool use remain unclear, in
large part due to the challenges associated with studying them. Imitation and tool use both involve translating
conceptual cognitive goals (i.e., knowing how to serve a tennis ball) into intricate sets of motor commands (i.e.,
accurately hitting a tennis ball with a racket). Hence, the study of imitation and tool use requires merging many
concepts from cognitive and motor neuroscience. This proposal aims to bridge this cognitive-motor divide by
developing a new theory of the common mechanisms supporting imitation and tool use that explains how
conceptual goals are actually turned into motor commands.
The proposed theory builds on our prior research by hypothesizing two interacting processing routes: (1) A
route that specifies actions in terms of the trajectory of the end-effector (e.g., writing letters), affording an
efficient means of defining desired tool or hand motion in an abstract (body-independent) manner, and (2) A
route that specifies actions in terms of body configurations, providing a more detailed but still computationally
tractable description of the positioning of the entire limb (and tool) throughout an action. While these two routes
typically work together, they may be engaged to different extents due to task demands (e.g., focusing on racket
trajectories or shoulder-elbow-wrist positions during a tennis serve) or when the different brain regions
supporting these distinct processing routes become disrupted. Thus, evidence of these two routes will be
established through novel task-switching paradigms in healthy individuals, measuring behavioral impairments
due to transient disruptions of relevant brain regions using transcranial magnetic stimulation, or by quantifying
chronic deficits in patients with left-hemisphere strokes. We will apply novel rigorous kinematic analyses to
assess behavior, correlate patient impairments with clinical measures of apraxia, and use recently-developed
multivariate lesion-symptom mapping approaches to confirm the neuroanatomical bases of these routes.
Together, such efforts will identify and characterize how trajectory and body-configuration planning support the
production and perception of imitation and tool use actions. Results will not only advance our understanding of
apraxia, highlighting alternative compensatory pathways that might be targeted for rehabilitation treatment, but
serves as a model for studying cognitive-motor interactions more broadly.

Public health relevance
PROJECT NARRATIVE Apraxia is a common, disabling, but poorly understood impairment observed in several neurological disorders, particularly following a left hemisphere stroke, that selectively affects the ability to perform daily activities such as imitation and tool-use (i.e., praxis). This project aims to identify how two distinct processing mechanisms, supported by different brain regions, both contribute to imitation and tool-use behaviors. This serves as an important step toward developing tailored neurorehabilitation programs that can identify and take advantage of those processes and brain regions that remain intact in patients after stroke.